Multimodal magnetoencephalography and electroencephalography exploration of the acute effects of THC exposure on neural noise and information transmission within working memory networks

ABSTRACT
Cannabis is one of the most widely used substances. As the legalization of both medical and recreational
cannabis sweeps across the country, the use and misuse of cannabis is expected to increase, likely related to
a decreasing perception of risk. Also, the concentration of the psychoactive component of cannabis, delta-9-
tetrahydrocannabinol (THC), has been on the rise in recreationally available cannabis over recent decades,
and of consequence, cannabis, especially high in THC, has been associated with detrimental cognitive and
mental health outcomes. THC is thought to disrupt cognitive function by altering the brain’s ability to transfer
and process information in cortical networks critical for perception, learning, and memory. Thus, there is an
urgent need to understand the psychophysiology of THC exposure. The objective of this study is to evaluate
acute effects of THC on proximal (magnetoencephalography / electroencephalography; MEG/EEG) and distal
(cognition) measures of brain function. This 2-test day, double-blind, placebo-controlled, cross-over study will
use advanced source analyses for multimodal MEG/EEG signals to determine the changes in the activity and
connectivity of cognitive neural networks induced by THC in non-users of cannabis (n = 20). To our knowledge,
this proof of concept study will be the first to use MEG/EEG to examine the acute effects of THC on brain
activity and connectivity and their relation to cognition.

Public health relevance
PROJECT NARRATIVE Cannabis use has been shown to affect working memory networks in human beings. Despite the increasing legalization and use of medical and reactional cannabis, there is a lack of studies in humans assessing the effects of cannabis and THC (the principal psychoactive constituent of cannabis) on information processing in working memory networks at the speed at which these processes occur. This study aims to use a combined magnetoencephalography (MEG) and electroencephalography (EEG) approach (MEG/EEG) to investigate the effects of THC on brain neural noise and fast information processing and transmission in working memory networks in humans.